GROWTH AND DIFFERENTIATION FACTORS IN BONE AND CARTILAGE

The objective of this project is to investigate the growth differentiation factors in cartilage and bone. The research projects currently under study are: 1) purification of osteogenins from bovine and human bone; 2) actions of growth factors on bone differentiation in vivo; 3) compartmentation of transforming growth factor beta in bone; 4) expression of TGF beta during cartilage and bone development; 5) influence of human and rat tooth matrix on bone induction; 6) role of insulin-like growth factors and other differentiation factors in cartilage repair, and 7) role of osteogenin and other growth factors on chondrocytes and dedifferentiated chondrocytes in vivo.